Liquid chromatography system replacement

ABSTRACT This supplement requests the funds to replace a no-longer supported Ultimate 3000 liquid chromatography system with a Vanquish Duo liquid chromatography system.

Public health relevance
ABSTRACT This supplement requests the funds to replace a no-longer supported Ultimate 3000 liquid chromatography system with a Vanquish Duo liquid chromatography system.